Acoustic and Physiological Outcome Measures for Laryngeal Dystonia

1 Project Summary/Abstract
2 Adductor laryngeal dystonia (AdLD) is a neurological voice disorder causing involuntary laryngeal spasms of
3 the larynx, leading to communication impairments. AdLD is diagnosed based on perceptual features, which
4 lack reliability and can present similarly to primary muscle tension dysphonia (pMTD). However, treatment for
5 the two disorders is vastly different. Misdiagnoses of AdLD delay treatment by 5–6 years, imposing financial
6 and quality-of-life burdens. No automated, clinically feasible objective diagnostic measures exist for
7 distinguishing the two disorders. Automated estimates of creak, defined as irregularly spaced vocal pulses
8 often perceived as vocal fry, show promise as a diagnostic marker for AdLD. Preliminary studies demonstrated
9 automated creak detection effectively differentiates AdLD from MTD with high diagnostic accuracy (AUC =
10 0.86). Understanding creak's physiological origins is critical. In typical speakers, creak occurs at the end of
11 breath phrases due to low subglottal pressure. In AdLD, creak occurs throughout the breath phrase,
12 suggesting distinct underlying mechanisms. Recent advances in accelerometer-based subglottal pressure
13 (ACC-Ps) estimation allow detailed physiological analysis during connected speech, making it feasible to study
14 in AdLD, pMTD, and controls. In the proposed study, a single experiment will record simultaneous speech,
15 ACC-Ps, and respiratory kinematics in speakers with AdLD, MTD, and controls reading aloud. An automated
16 creak detector will analyze speech data. Our first aim is to investigate the underlying physiology of creak in
17 speakers with AdLD by measuring subglottal pressure in connected speech. Our second aim will evaluate
18 discriminative accuracy of creak that occurs early in the breath group phrase, called early-phrase creak,
19 between speakers with AdLD, speakers with MTD, and controls. We will benchmark the discriminative
20 performance of early-phrase creak against standard clinical measures used to measure voice. The dataset
21 collected in this project will serve as pilot data for an R01 application to develop creak-based diagnostic tools,
22 which may improve differential diagnosis of AdLD and MTD, thus mitigating the current delay in diagnosis and
23 treatment of this debilitating voice disorder.

Public health relevance
Project Narrative The lack of quantitative measures for differential diagnosis of Adductor Laryngeal Dystonia (AdLD) from other voice disorders significantly impacts public health by causing prolonged diagnostic delays, misdiagnoses, and untreated communication impairments that reduce quality of life and increase financial burdens. Developing an automated, objective diagnostic tool to differentiate AdLD from similar conditions like primary muscle tension dysphonia (pMTD) could streamline referrals and improve access to effective treatments, mitigating these burdens. By validating "creak" as a diagnostic marker and investigating its physiological basis, this research aims to reduce diagnostic delays and enhance clinical decision-making, ultimately improving outcomes for individuals with voice disorders.